Extensively drug resistant Pseudomonas aeruginosa keratitis outbreak strain: virulence mechanisms and mitigation

Project Summary / Abstract
The recent outbreak of keratitis caused by an extensively drug-resistant (XDR) strain of Pseudomonas
aeruginosa with blaVIM-80 and blaGES-9 associated with preservative free artificial tears is concerning
because the infecting bacteria was resistant to all tested antibiotics currently used to treat bacterial keratitis. As
of May 2023 the CDC and other health departments had reported 81 patients in 18 states infected with this
strain. Of these, 14 cases of vision loss associated with this infection had been recorded (a rate of 17.3%),
including four cases of enucleation. Of great concern is that four patients have died within 30 days of culture
collection. This progression to loss of the globe secondary to keratitis is extremely atypical as microbial
keratitis rarely progresses to endophthalmitis. For instance, only 0.5% of microbial keratitis cases resulted in
endophthalmitis in a recent large-scale study. In addition, our preliminary data, based on whole genome
sequencing of the outbreak strain, in vitro antibiotic susceptibility testing, and rabbit keratitis studies, suggests
that this strain has unique qualities that contribute to its pathogenesis. This includes extremely high resistance
to standard of care antibiotics, the ability to survive and proliferate beyond typical strains in vivo, and an
unusual virulence factor armament. The outbreak isolate groups phylogenetically with “cytotoxic” strains, but
lacks type III secretion system (T3SS) toxins associated with cytotoxic or invasive strains. Such atypical strains
that lack T3SS toxins represent 25% of keratitis isolates, yet have not been studied to investigate other
virulence mechanisms that they employ.
Because of the critical threat to vision caused by this strain and the lack of a good treatment approach,
the objective of this study is to identify the mechanisms underlying the enhanced virulence of the outbreak
strain, and to develop better therapeutic approaches to treat ocular infections caused by this XDR P.
aeruginosa strain. The long-term objective is to generate mechanistic and translational information that can
lead to antivirulence and antibiotic strategies in order to save vision from infections caused by this and future
highly drug resistant bacterial infections of the eye. A major goal of this study will be to systematically test
these and other candidate virulence factors unique to this outbreak strain in establishing keratitis and keratitis
outcomes (Aim 1). A second goal will be to mitigate the threat of this strain by testing FDA approved
antimicrobials and combinations not currently used in the eye (Aim 2). Based on our intriguing preliminary data
and the impetus of this new pathogenic threat, we are poised to test the hypothesis that this outbreak strain is
a new type of keratitis-causing P. aeruginosa, neither classically cytotoxic or invasive, that uses different
virulence factors to establish infection.
This study can have long-term impacts on the field by 1) providing information to help uncover why this strain
concerningly appears to have the ability to spread from the cornea to deeper ocular tissues and cause life
threatening systemic infections that can inform future anti-virulence strategies, and 2) development of more
effective ocular antibiotic formulations that could be used to treat XDR bacterial infections. Furthermore, our
team is uniquely situated to make rapid advances in understanding this form of keratitis based on our
experience and having an active animal model of this disease demonstrating our ability to discern clinically
relevant differences in virulence and antibiotic efficacy.

Public health relevance
Project Narrative A recent outbreak of eye infections stemming from the use of contaminated bottles of artificial tears - these infections were caused by a particularly dangerous bacterium that is resistant to the antibiotics that clinicians generally use to treat eye infections. Unusually, these infections have spread beyond the eye resulting in death in some cases. The goal of this study is to learn more about how the bacteria causes infection and how to treat it.